Administrative Core

Project Summary
The overall goals of this P20 application are (1) to identify ancestry-specific genetic regulators of macrophage
function and response to anti-HER2 antibody therapy that potentially underlie racial differences in response to
this targeted immunotherapy and (2) to establish a robust infrastructure to support and develop innovative,
productive immuno-oncology and health disparities research collaborations. The Administrative Core facilitates
this goal by providing an overall organizational infrastructure, integration with existing CCSG-supported Cancer
Center resources, a system for financial management, and overall governance. Specifically, the Administrative
Core provides the overall leadership, management, and coordination of all Research Project activities and
facilitates the meetings of the Executive Committee, Planning Committee, and Internal Advisory Committee. All
official communications among P20 participants originate from the Administrative Core. Specifically, the aims of
the Administrative Core are to provide leadership and oversight of all P20 activities by (1) convening an Executive
Committee for monthly progress review, including monitoring of specific timeline/milestones for Project and
Planning Committee deliverables, (2) providing fiscal and resource management for each component of the P20,
(3) ensuring compliance with all NIH and institutional grant regulations, and (4) facilitating communications
between P20 investigators and the National Cancer Institute. We will also facilitate the development of
multidisciplinary collaborations and grant proposals in immuno-oncology and health disparities by establishing a
Planning Committee with cross-cutting expertise in cancer immunology, molecular epidemiology, social
determinants of health, and translational science and implement a structured process for developing multiple
extramural grant proposals. Finally, we will support integration of health disparities and immuno-oncology
research into the Cancer Center overall by convening an Internal Advisory Committee (IAC) to ensure program
integration and optimization of resources from the comprehensive cancer center.

Public health relevance
Project Narrative The Administrative Core contributes to the overall efficiency of the P20 by centralizing and leveraging the existing administrative infrastructure of the Karmanos Cancer Institute (KCI), an NCI-designated Comprehensive Cancer Center, thereby streamlining processes and eliminating duplication of effort. This robust administrative infrastructure conserves the resources of KCI’s Research Administration and allows investigators the ability to concentrate on the science of this P20, establish meaningful and productive multidisciplinary collaborations, and develop large-scale extramural grant submissions.